Team-based Interdisciplinary Cancer Research Training Program

TEAM-BASED INTERDISCIPLINARY CANCER RESEARCH TRAINING PROGRAM
PROJECT SUMMARY/ABSTRACT
In advancing innovative ways to address complex cancer challenges, there is a growing trend to bring together
scientists with knowledge and perspectives from different disciplines. The emphasis on developing relationships
across scientific disciplines and adopting collaborative interdisciplinary approaches to scientific discovery has
been recognized and shown to lead to significant advances in our fundamental understanding of cancer and its
clinical management. In addition, it is abundantly clear that such advances rarely occur in isolation but typically
represent team-based research endeavors. We believe that early exposure of trainees to interdisciplinary
education and training coupled with team-based learning and research environments will better position them
for successful careers in any area of cancer research. At present, there are no existing NCI-funded T32 programs
devoted to team-based training. This concept is emphasized in our proposed Team-based Interdisciplinary
Cancer Research Training (TICaRT) Program. The Program is based on four premises: 1) interdisciplinary
training in team science will be critical in preparing future generations of cancer scientists; 2) team-based
research translates into an improved training environment by providing trainees with access to scientists in
different disciplines; 3) Florida needs a continuous supply of highly-trained cancer researchers including women,
underrepresented minorities and individuals with disabilities; and 4) program graduates must have the skills to
translate their knowledge and experience to achieve successful cancer research careers in academic, industry,
or government positions. Our goal is to develop a cadre of outstanding independent investigators in a training
program that encompasses cancer research across disciplines and unites laboratories, trainees, and mentors in
areas, including dentistry, engineering, medicine, nursing, pharmacy, public health, veterinary medicine, and
communication. The TICaRT program capitalizes on our existing strengths at the University of Florida, including
a core of well-established and productive investigators, outstanding research facilities, an exemplary record of
collaboration, excellent institutional commitment, and a culture of successful mentorship of graduate students,
post-doctoral fellows and early stage faculty. We have assembled a cohesive group of 29 basic science and
clinical faculty from 22 departments, 9 Colleges, and 10 PhD Programs. Upon entering the TICaRT Program,
each member of the trainee team will create and implement a tailored training plan under the guidance of his/her
faculty mentors. Trainees will achieve their research and career development objectives through a combination
of didactic, research, and professional development activities. The TICaRT Program requests NCI support for 1
pre-doctoral and 3 post-doctoral trainees; support for 2 additional pre-doctoral trainees is pledged by our
institution. The TICaRT T32 is led by a Director and two Co-Directors, who will obtain input from Internal and
External Advisory Boards, and ongoing program evaluations and quality improvement will be in place to ensure
the long-term success of the trainees.

Public health relevance
TEAM-BASED INTERDISCIPLINARY CANCER RESEARCH TRAINING PROGRAM PROJECT NARRATIVE Cancer is a major public health concern and training the next generation of cancer researchers is critical to the success of our national effort to improve cancer outcomes. We propose to develop a novel Team-based Interdisciplinary Cancer Research Training Program that will provide comprehensive training for both pre- doctoral and post-doctoral candidates by expert faculty members drawn from various scientific disciplines focused on cancer research. The Program is designed to build a group of rigorously trained, scientifically competent, and innovative young scientists who are qualified to lead interdisciplinary team-based research initiatives and have the skills to make a difference in the lives of individuals with cancer, population health, and cancer health policy through cutting edge research.